Immunometabolic Regulation of MDSCs in Periodontitis

PROJECT SUMMARY/ABSTRACT
Periodontitis is a common chronic inflammatory disease affecting over half of the US adult population and
characterized by destruction of the supporting structures of the teeth. Although there is a clear relationship
between increased obesity and periodontal disease incidence, the mechanisms that underpin the links between
these two conditions are not completely understood. Chronic low-grade systemic inflammation in response to
obesity, referred to as metainflammation, is a consequence of immune dysregulation that results from the
continuous exposure to bacterial lipopolysaccharide and saturated free fatty acids under hyperglycemic
conditions. Obesity is known to cause the expansion of immature myeloid cells, termed myeloid-derived
suppressor cell (MDSC) populations, which can differentiate into mature osteoclasts, resulting in alveolar bone
loss. In this application, it is hypothesized that MDSC expansion and mobilization contribute towards obesity-
associated periodontitis through MDSC metabolic reprograming with increased osteoclastic capacity contributing
towards alveolar bone loss. The aims outlined in this application will address questions to determine: 1) the
mechanisms that govern obesity-directed MDSC subpopulation mobilization and function in the periodontal
microenvironment; 2) how obesity or HFD, independent of obesity, contributes toward M-MDSC osteoclastogenic
reprogramming potential, and 3) if obesity status contributes towards differences in MDSC subpopulations in
human periodontal disease. At the conclusion of these studies, new evidence will be provided related to the
cellular mechanisms engaged during diet-induced obesity that contribute towards periodontal disease
susceptibility and progression through MDSC populations in mice and humans.

Public health relevance
PROJECT NARRATIVE Periodontitis is a common chronic inflammatory disease characterized by destruction of the supporting structures of the teeth. Although there is a clear relationship between degree of obesity and periodontal disease incidence, the mechanisms that underpin the links between these two conditions are not completely understood. This application seeks to understand the impact of immature myeloid cells in obesity-associated periodontal disease which will provide mechanistic insight linking obesity and dietary changes with oral bone quality in health and disease.